Mechanism of Integrative Metabolic Regulation by Iron and Hypoxia

PROJECT SUMMARY
Insulin resistance, excess hepatic glucose production, and impaired insulin secretion are the hallmarks
of type 2 diabetes mellitus (T2DM), and tissue iron levels significantly affect all three. In mice and humans, we
have shown that high iron impairs insulin secretion and down regulates leptin and adiponectin. Our preliminary
data show further that these effects of iron are fuel-dependent, with much of this difference based on higher
iron levels supporting higher levels of fat oxidation. Our mechanistic work on these effects of iron has revealed
the involvement of numerous pathways, including transcriptional regulation (notably by CREB, FoxO1, and
PGC1α) and nutrient/metabolite signaling (AMPK, sirtuins, and mTOR). Thus, the effects of iron are complex,
pleiotropic, and cannot be explained by invoking a single linear signal transduction pathway.
Recently our work on the mechanism by which iron regulates leptin secretion has revealed a unifying
concept for these pleiotropic effects: High tissue iron down-regulates a central integrator of nutrient and redox
status, the O-linked N-acetyl glucosamine (O-GlcNAc) pathway. This pathway results in the O-GlcNAc
modification of most transcription factors and numerous enzymes that regulate metabolism. Activation of the
pathway is often a direct readout of cellular nutrient fluxes, and we have shown it to be sufficient to induce
changes in insulin sensitivity, insulin secretion, and hepatic glucose metabolism in ways that recapitulate
T2DM. A second pathway that responds to both nutrient and oxidative stresses is the hypoxia-sensing
pathway. Like the O-GlcNAc pathway, it functions at both ends of two metabolic spectra—low glucose and low
oxygen as well as high glucose and oxidative stress. The pathways regulate one another and interact in
determining hepatic glucose production, insulin sensitivity, and insulin secretion. Importantly, both the O-
GlcNAc and hypoxia pathways are not only relevant to pathologic iron overload and hypoxia, but regulate
metabolism in normal physiology, across the very broad range of “normal” iron and in individuals at sea level.
In sum, the O-GlcNAc and hypoxia pathways cooperate to sense the availability or excess of two
essential elements required for oxidative metabolism, iron and oxygen. Based on the above, our published
work, and Preliminary Data, we therefore hypothesize that these two pathways integrate these signals to
regulate several metabolic pathways involved in the pathogenesis of T2DM. Modulation of the O-GlcNAc
pathway by iron affects numerous signal transduction pathways, leading to broad-based changes in
metabolism that globally alter fuel utilization to confer adaptive responses to either a lack or excess of iron. In
parallel, the hypoxia pathway performs a parallel function based on oxygen availability or excess oxidant
stress. Crosstalk between the two pathways can amplify their effects, resulting in integration and a “fine-tuning”
of metabolism based on nutrient availability, iron and oxygen levels, and oxidant stress. To test these
hypotheses, we propose the following Specific Aims:
1. Determine the mechanism by which O-GlcNAc mediates the regulation of leptin secretion by iron.
2. Define the effects of dietary iron on β-cell function in mice, in normoxia and hypoxia.
3. Determine the mechanism for the effects of iron on O-GlcNAc protein modification.
The significance and impact of these studies is that they aim to define ideal levels of tissue iron that
may be narrower than the broad “normal” range in humans, and tissue iron is easily modifiable by diet or blood
donation. Ideal iron levels may also differ based on oxygen status (i.e. in those with different habitation
altitudes), ultimately allowing personalized therapy for diabetes in those individuals. Finally, the studies will
also identify new pathways to treat diabetes: For example, the HIF hydroxylases can be pharmacologically
manipulated, and advances are also being made in doing so for the O-GlcNAc pathway.
!

Public health relevance
PROJECT NARRATIVE We have studied a novel and easily modifiable risk factor for diabetes, namely high tissue iron levels, that we have shown impairs insulin secretion, one of the hallmarks of type 2 diabetes. More recent work has indicated that many of these effects are mediated by two pathways, the so-called hypoxia sensing pathway and a nutrient sensing pathway that modifies proteins with a sugar, GlcNAc. In mouse models and in humans, we have shown that these pathways interact with iron to determine insulin secretion and production of a major regulator of metabolism, leptin. Major changes in blood glucose levels can be achieved by manipulating one or both. We therefore propose studies to further define these effects and their molecular mechanisms, focusing on a pathway that we have found to integrate iron status in other tissues. Our goal is to define potential new targets for diabetes therapy, and define personalized “ideal” iron levels for diabetes prevention and treatment. !